Understanding membrane proteins' allosteric modulation with cryo-EM

Project Summary/Abstract
My laboratory's research is focused on understanding the molecular mechanisms key to the regulation of
membrane protein function and to the modulation of their output signaling. We use cryo-EM and advanced
classification methods, such as manifold embedding, combined with modeling and molecular dynamics to
study how ligands produce shifts in conformation equilibria and bias signaling output. We are currently studying
two systems that allow us to study how different types of ligands influence the gating of ion channels.
We are studying the role of lipids in triggering gating of mechanosensitive channels of the MscS family, a
model system of membrane tension-sensing which can yield important information about the fundamental
principles governing ion channel gating and the role that lipid-protein interactions play in this process.
We have a longstanding interest in the mechanism and modulation of the ryanodine receptor (RyR), a calcium
release channel fundamental to heart and skeletal function. We are using manifold embedding, a machine
learning-based method to analyze cryo-EM images, to better understand how small molecules and ions such
as calcium and ATP affect the conformational energy landscape of the channel. We aim to shed light on the
gating mechanism of this very large ion channel, a prerequisite to understanding of its modulation by protein
ligands, post-translational modifications and drugs.
Our approach to these fundamental problems is to use a commbination of cryo-electron microscopy, advanced
image classification techniques, modelling and molecular dynamics simulations to delineate allosteric
pathways mechanistically and then test proposed models with biophysical methods such as single-channel
measurements, HDX-MS and mutagenesis.
Our ultimate aim is to greatly increase our molecular understanding of the gating and allosteric modulation of
ion channels. Progress towards such knowledge has the potential to open the way for the design of small
molecule allosteric modulators with very well controlled effects on their targets, aiding the development of
drugs with limited side effects.
A longer-term aim is to further develp and use our tools towards gaining a better understanding of allosteric
modulation in other classes of membrane proteins of therapeutic importance. In particular, G protein-coupled
receptor ligands can induce the selective binding of different transducers in a process called biased signaling.
The molecular mechanisms at play in this process are still poorly understood despite their fundamental
importance for the development of safer drugs.

Public health relevance
Project Narrative Ion channels are involved in a large number of vital processes, such as heart and muscle function for the ryanodine receptor and function of kidneys and regulation of blood pressure for mechanosensitive channels. This work focuses on understanding the function and regulation of ion channels. Better understanding of small ligand and lipid-protein interactions in these channels can lead more generally to a better understanding of ion channels function and to the design of drugs treating the numerous diseases associated with their malfunction.